Leveraging environmental drivers to predict vector-borne disease transmission

Project Summary
The overarching goal of my research program is to understand the dynamics of ecological systems
and their influence on diseases in humans, plants, and animals to improve the health and wellbeing of
humans and ecosystems. Vector-borne diseases are a growing public health problem that are intimately
linked to climate, land use, and other environmental changes. Our current and future research is focused on
understanding changes in vector-borne disease burdens in response to global change. Predictive approaches
that mechanistically link environmental change to disease dynamics are necessary to disrupt transmission and
to sustainably control outbreaks.
Research in my lab uses a diverse quantitative toolkit and emerging sources of data to predict disease
dynamics, uncover environmental mechanisms for transmission, attribute impacts of global change, and
forecast changes in the landscape of infectious disease. In the next five years, we will build on our
understanding of climatic drivers of vector-borne diseases to study the impacts of climate extremes, the
limitations on and drivers of vector species range expansions, and the role of adaptive (co)evolution. We will
disentangle the multidimensional effects of land use change on vector-borne diseases by combining
hypothesis testing, novel causal inference methods, and geospatial datasets to uncover the land use niches for
disease transmission. Our focal systems include dengue, malaria, leishmaniasis, schistosomiasis, yellow fever,
Lyme disease, and their mosquito, sandfly, and tick vectors. Our work combines publicly available
environmental and epidemiological data and partner-engaged research with vector control and health
agencies. We apply mechanistic mathematical models, machine learning, econometric causal inference,
empirical dynamic modeling methods, and other quantitative tools. We also conduct primary empirical research
on mosquito and parasite thermal adaptation on the Western treehole mosquito and its ciliate parasite.
We are now witnessing unprecedented impacts of anthropogenic climate and land use change alongside
expansions and resurgences of vector-borne and zoonotic diseases. At the same time, expanding
technological and computational capacity are accelerating the pace of infectious disease dynamics research.
This is an exciting and critical time to study linkages between human and planetary health, and my
research program is at the forefront of this emerging field. By discovering mechanistic linkages between
environmental change and disease transmission, we can design more proactive control measures, develop
policy that benefits people and the environment, and prevent and reverse the worst impacts of anthropogenic
change on health and their disproportionate impacts on marginalized populations.

Public health relevance
Project Narrative Climate and land use change are increasingly disrupting ecosystem function and human health, and altering patterns of disease transmission. The overarching goal of my research program is to develop a mechanistic understanding of disease dynamics by applying quantitative tools to better predict, prevent, and respond to the changing landscape of infectious diseases. Our work focuses on understanding the climatic, environmental, and behavioral drivers of vector-borne disease transmission with an emphasis on discovering mechanism and informing policy to improve control.